The Impact of Adversity on Neurobiological and Psychosocial Dimensions of the Stress Response System

PROJECT SUMMARY/ABSTRACT
Childhood adversity (CA) is one of the most potent risk factors for psychopathology across the lifespan, largely
due to enduring disruptions in the body’s stress response system. Further, the cascade of molecular and
neurobiological transformations following CA distinguishes patients from non-exposed counterparts, spurring a
more pernicious course of illness, greater symptom severity, more comorbidities, and less favorable response
to treatments. Thus, there is an urgent need to identify transdiagnostic mechanisms of risk. This proposal
facilitates the long-term goal of identifying intervention targets, guided by evidence that adolescence is a period
of vulnerability to stress that is accentuated by prior CA exposure. To date, investigations of neural,
physiologic, and behavioral stress response deficits following CA have been conducted in relatively separate
literatures, and the majority of these studies have taken a cumulative risk approach (i.e., “total adversity”)
without attention to shared features among certain types of CA. Further, investigations of regulatory processes
have generally examined either broad-level dysregulation or honed in on only regulatory strategy (e.g.,
reappraisal), neglecting to account for the dynamic nature of stress responsivity. This proposal addresses a
critical gap in current research by examining a comprehensive set of stress responses, including emotion
reactivity, emotion regulation (ER), and ER flexibility, each of which is a malleable target for intervention,
spanning multiple units of analyses. Specifically, this study will examine CA characterized by threat (e.g.,
abuse, witnessing domestic violence), physiologic reactivity across multiple systems (i.e., HPA axis,
parasympathetic and sympathetic branches of the autonomic nervous system), and neural activation during an
fMRI paradigm that allows for an assessment of initial stress reactivity as well as ER strategy selection,
implementation, and flexibility (i.e., evaluation and modification of a strategy based on the stressor/context).
The sample will be comprised of 100 adolescents, aged 14-16 with varying levels of threat exposure. In
addition to the initial assessment, participants will complete a six-month follow-up to measure prospective
psychopathology symptoms, addressing a secondary focus of this proposal linking stress response patterns to
internalizing and externalizing pathology. Employing a multi-unit analysis of acute stress responses will
facilitate the characterization of precise CA-related decrements in reactivity and regulation that confer
psychopathology risk during a crucial developmental period.

Public health relevance
PROJECT NARRATIVE This project aims to examine the role of dynamic emotion regulation processes (i.e., reactivity, regulation, and flexibility) at the behavioral and neurophysiological levels as a proximal indicator of psychopathology risk following exposure to traumatic stress (threat) in childhood. This proposal has both scientific and clinical significance, as there are few studies clarifying the contribution of cross-system regulatory processes in relation to threat and the emergence of psychopathology. This research has the potential to identify factors that inform when adolescents are at greatest risk for mental health spurred by stress vulnerability and to identify prescriptive targets for intervention during these periods.